The Lung Endothelium as an Instructive Niche for the Innate Immune System during Vascular Injury

ABSTRACT OF PROGRAM
The loss of lung vascular barrier integrity in settings as diverse as trauma and bacterial or viral infections is a
hallmark of acute lung injury (ALI) and its serious variant ARDS. ALI is characterized by protein-rich edema and
ultimately respiratory failure. Targeted therapies remain an urgent unmet need. It is now becoming increasingly
clear that the lung endothelium is a complex monolayer, almost an organ itself, consisting of not only alveolar
endothelial cells (EC) but also specific EC populations found in pulmonary microvessels, arteries and veins.
Recently, we have shown using RNA-sequencing that the lung EC demonstrate significant upregulation of genes
involved in processes related to immune function such as leukocyte cell adhesion, leukocyte migration, and
regulation of immune system. This finding was consistent with lung EC being continuously exposed to the
external environment, unlike EC in other organs such as the brain or heart. Studying this immune regulatory
function of the lung endothelium is crucial for understanding how the EC controls immunity and the host defense
function of lungs, and also how its dysregulation or impairment of the immune response leads to pathogenesis
of ALI. This Program builds on the extraordinary success of a previous 20-year entity, evident by our
accomplishments. We have helped establish the lung endothelium as a node for understanding the lung’s
response to infection and injury and our work has led to better understanding of ways of treating endothelial
barrier breakdown in lungs. This revised application, focusing on the enigmatic innate immune function of the
lung endothelium, is built on foundations of synergy and collaborations. Our Supporting data show the central
role of the lung endothelium in driving inflammatory lung injury, and at the same time provides clues that will lead
to new lung injury targeting therapies. Project 1 will test the hypothesis that the post-translationally modified
endoplasmic reticulum-localized spinghosine-1-phosphate receptor S1PR1 in an unexpected manner
reprograms lung endothelium to activate a signaling cascade that induces inflammatory lung injury. Project 2
will test the hypothesis that a novel lung endothelial cell expressed ubiquitin E3 ligase CHFR (checkpoint with
fork-head and ring finger domain) identified by us regulates VE-cadherin-mediated endothelial barrier integrity
and lung’s innate immune function. Targeting CHFR thus holds promise for preventing inflammatory lung injury.
Project 3 will test the hypothesis that lung endothelial mitochondrial dysfunction and induction of mitophagy
regulate endothelial regeneration and serve as a key check point for restoring homeostasis and preventing
inflammatory injury. These Projects are supported by innovative scientific Cores (Epigenetics and
Transcriptomics (Core B), Cellular Imaging (Core C), and Intravital Imaging and Physiology (Core D) that
will make it possible to rigorously address the innate immune function of the lung endothelium and its role in
orchestrating restoration of homeostasis. We hope to unravel the innate immune function of the lung
endothelium, thus providing strategies to develop new targeted therapies against ALI and ARDS.

Public health relevance
NARRATIVE Severe infections and inflammation of the lung leads to build-up of fluid in the lung, resulting the devastating Acute Respiratory Distress Syndrome (ARDS), in which patients have to be placed on ventilators and for which there are no effective treatments. We have found that lung blood vessel endothelial cells can function as immune cells and are essential to the development of the disease. By understanding this newly recognized function of lung endothelial cells, this Program Project will identify molecules that can be targeted for the development of new ARDS treatments.